Area A: High Precision Single Cell Genomes: Linear Amplification and Digital Haplotypes

Project Summary/Abstract This proposal brings together four research teams with expertise in cancer genome sequencing, single-­cell sequencing, and cancer cell biology to advance single-­cell sequencing technology to tackle compelling questions in basic and translational cancer research. It responds to RFA-­CA-­17-­023, Cancer Moonshot Initiative, and proposes to create and validate a platform of experimental and analytical approaches for precise single-­cell sequencing of human samples based on the most recent advance in single-­cell whole-­genome amplification, Linear Amplification after Transposon Insertion (LIANTI), developed by the Xie laboratory. The immediate goal is to further develop LIANTI and augment bioinformatic analysis for single-­cell LIANTI sequencing. Aim 1 focuses on developing a high throughput version of LIANTI. Aim 2 focuses on developing computational methods that utilize the digital and linear nature of LIANTI sequencing data. Aim 3 describes strategies and experimental models that will be used to validate and benchmark single-­cell LIANTI sequencing performance and demonstrate its applicability to tumor analysis. Overall, our goal is to optimize and implement the most precise single-­cell sequencing technology for variant detection in single cancer or somatic cells. Success of the project will result in an integrated platform that overcomes prevailing impediments in single-­cell analysis and can have a transformative impact in multiple areas of cancer research, including tumor genetic heterogeneity, circulating tumor cells, primary/metastasis relationship, drug resistance, and benign-­to-­ malignancy transformation.

Public health relevance
Project Narrative We will further develop single- cell whole- genome amplification technologies, Linear Amplification after Transposon Insertion (LIANTI), and companion bioinformatic analysis pipelines. We will benchmark and validate the potential for detecting single- nucleotide variants, chromosomal rearrangements, and absolute DNA copy number in a single cell genome by LIANTI sequencing both using cancer cell lines and by live- cell experiments.